High-resolution multi-color FLIM-FRET tomography of whole organism

DESCRIPTION (provided by applicant): Resonant Energy Transfer (FRET) imaging has long been established as the best method for detecting protein interaction and sensing physiological state in living systems. However, 3D in vivo FRET imaging of whole organism remains highly challenging, because existing microscopy methods cannot perform deep- penetrating sub-cellular multi-channel FRET imaging. We propose to develop a deep tissue Fluorescence lifetime imaging (FLIM) method, named Lifetime Excitation-Emission Matrix Scanning Laser Optical Tomography (LEEM-SLOT) to: 1. Perform isotropic sub-cellular 3D imaging in deep tissue, 2. Perform multi- color FRET imaging in one scan, 3. Fully analyze multi-color FRET. LEEM-SLOT will permit fast FLIM tomography and reconstruction of lifetime images in 4x4 excitation emission matrices with 1-μm isotropic resolution over 500-μm depth. Lifetime analysis of spectrally unmixed LEEM images will allow parallel visualization of multiple FRET channels with CFP/GFP/YFP/mCherry and equivalents. We will apply the LEEM-SLOT method to two pilot studies of: 1. Map Kinase pathway activation in Ciona heart progenitor cells, and 2. Intracellular cAMP level during renal cystogenesis in live zebrafish. Through these studies we expect to establish the LEEM-SLOT method as a novel tool for studying the regional activation of signaling pathways in live embryos or tissues, and performing multi-modal FRET biosensing in live organisms. PUBLIC HEALTH RELEVANCE: The LEEM-SLOT method will serve as a general imaging platform for obtaining comprehensive insights on cell- biological mechanisms of development and diseases.

Public health relevance
The LEEM-SLOT method will serve as a general imaging platform for obtaining comprehensive insights on cell- biological mechanisms of development and diseases.